HHSN268201100004C, MODIFICATION #5, 3-8470187 OPTION PERIOD 2 BASE, PERIOD OF PER

The Women's Health Initiative (WHI) was established to elucidate the etiology and prevention of CVD, cancers, and osteoporosis in women aged 50–79 years.